Organizational resilience: A novel strategy for improving ICU outcomes

PROJECT ABSTRACT
Intensive care unit (ICU) teams (i.e., nurses, physicians, and respiratory therapists) have some of the highest
rates of burnout in healthcare. Burnout is an occupational phenomenon resulting from chronic workplace stress
and is characterized by exhaustion, depersonalization, and reduced professional efficacy. Burnout has been
associated with poorer safety ratings, quality of care, and patient outcomes. Interventions to reduce burnout
have focused on individual clinicians, but this approach neglects the organizational factors contributing to
burnout, and consequently, has been only marginally effective. Organizational resilience is a promising
approach for addressing burnout in ICU teams and improving outcomes in patients with acute respiratory
failure. Organizational resilience is the capacity of a complex adaptive system to anticipate stressors, perform
under stressful conditions, and adapt moving forward. While the relationships among organizational resilience
and employee health and performance outcomes have been described in other settings, organizational
resilience has not been measured in healthcare settings. Our scientific premise is that the key to improving
ICU clinician burnout and preventing adverse outcomes in patients with acute respiratory failure is to
investigate the role of organizational factors in ICU resilience. When ICUs are more organizationally
resilient, clinicians feel better equipped to manage workplace stressors, and thus are more likely to provide
high-quality care for patients with acute respiratory failure. Capitalizing on our team’s expertise in ICU
organization and survey research, our partnership with CommonSpirit Health, the 4th largest U.S. healthcare
system with hospitals in 21 states, and our preliminary data, we propose a novel mixed-methods sequential
explanatory design study that examines resilience as an organizational phenomenon. We will administer
a survey about resilience (Connor-Davidson resilience scale and Lee et al’s measure of organizational
resilience), burnout (two single-item Maslach Burnout Inventory measures), and wellbeing (WHO-5) to 6000
clinicians working in 60 ICUs at two timepoints to examine the dynamics of individual and organizational
resilience over time (Aim 1). We will then test the interdependent contributions of individual and organizational
resilience to patient outcomes (mortality and ventilator-free days) and clinician outcomes (burnout and
wellbeing) (Aim 2). Lastly, we will qualitatively describe the relationships between work environment, ICU
organizational resilience, and interprofessional care and characterize perceived barriers and facilitators of
organizational resilience (Aim 3). Our long-term goal is to develop a multi-pronged intervention that will
enhance ICU resilience. Our objective in this proposal is to empirically test the relationship between resilience
and patient and clinician outcomes so that administrators, policymakers, and researchers can more
appropriately target efforts to support ICU clinicians. This project addresses a major gap in understanding how
to best support a valuable healthcare resource: the clinicians that care for mechanically ventilated adults.

Public health relevance
PROJECT NARRATIVE Clinician burnout—particularly in ICUs—has persisted, despite widespread recognition of this problem. This study will yield valuable information about a crucial missing piece of the puzzle: how organizational factors contribute to burnout in ICU clinicians and adverse, preventable outcomes in patients with acute respiratory failure. By generating novel evidence about the factors that promote organizational resilience in ICUs, the study will lead to improvements in quality of care for patients with acute respiratory failure.